Planning and Evaluation Core

ABSTRACT – PLANNING AND EVALUATION CORE
In line with our long-term goal to eliminate cancer health disparities in Florida, California and nationally, the
University of Florida (UF), Florida A&M University (FAMU) and University of Southern California (USC)
have formed a triad partnership to establish the Florida-California Cancer Research, Education &
Engagement (CaRE2) Health Equity Center. The Planning and Evaluation Core (PEC) of the CARE2 Health
Equity Center will implement a systematic planning and assessment plan that guides program improvement
and document accountability, and effectiveness. The specific aims of the PEC are to: (1) provide operative
planning of internal and external partnership activities for CaRE2 Center’s cores and projects (2) prioritize and
support three additional collaborative research projects to expand cancer disparities research nationally; (3) To
foster continuous quality improvement and demonstrate the impact of the partnership, the PEC will continue to
track, monitor, and evaluate all partnership activities; and (4) To provide independent assessment and
guidance, the PEC will continue to foster the tracking, monitoring and evaluation of partnership activities by the
Program Steering Committee (PSC) and the External Evaluator. Using clear metrics to assess the outcomes of
each core and project, PEC will support the aims of the CaRE2 Center by providing the guidance and oversight
to ensure continuous quality improvement. The expected outcomes for the PEC are: (1) evidence documenting
the success of scholarship activities and tracking processes among UF, FAMU and USC scientists; (2)
documentation of the effectiveness of the bi-monthly web-based partnership meetings and annual face-to-face
retreat; (3) findings from the social network analysis that documents changes in scientific collaborations across
the CaRE2 Center; and (4) assessment of the congruence between objectives, activities, and outcomes across
the cores.